Mechanisms of epithelial alterations in diabetic cornea

Diabetes is the most widespread blinding disease in working-age adults. Up to 70% of diabetic patients suffer
from corneal problems including neuropathy and epithelial keratopathy (delayed wound healing, recurrent
erosions, ulcers) that impair vision and cause pain and discomfort. Diabetic keratopathy is underdiagnosed,
and therapy remains symptomatic. We identified markers altered in human diabetic corneas and restored their
normal-like levels in corneal organ cultures by gene and nano therapy, which also restored normal stem cell
phenotype and corneal wound healing. Epigenetic changes also appear to contribute to diabetic complications.
In the previous funding period, we designed new approaches to normalize diabetic corneas (1) to avoid toxicity
and (2) to remove stable epigenetic changes in diabetic cells. We developed nontoxic nanobioconjugates
(NBC) that efficiently normalized stem cell marker expression and wound healing in cultured LEC and organ-
cultured corneas, based on antisense modulation of c-Met, MMP-10, and cathepsin F expression. We also
discovered a new marker, Wnt5a, reduced in diabetic corneas by dual DNA methylation and microRNA-203
epigenetic suppression. Addition of Wnt5a or demethylating agent Decitabine to diabetic cells or corneas
restored wound healing kinetics and stem cell marker expression. In another approach, we produced induced
pluripotent stem cells (iPSC) from diabetic LEC to remove diabetic epigenetic signatures and differentiated
them back to potentially normalized limbal-like epithelium. Such formerly diabetic cells expressed several stem
cell markers similar to normal, as we expected. In this proposal, we will optimize normalization of human
diabetic corneas structurally (by stem cell marker expression) and functionally (by wound healing kinetics).
We hypothesize that (1) a combination of NBC targeting several diabetic markers with DNA demethylating
agents would provide more efficient diabetic corneal normalization than single therapies, and (2) iPSC-derived
LEC-like cells could be differentiated into transplantable corneal epithelial cells using air-lifting and natural
corneal surface support. We aim to understand mechanistically how the normalizing treatments change gene
and protein expression levels and affect corneal cell populations using validated single-cell RNA-seq approach.
Aim 1. To develop combined nano and epigenetic therapy for diabetic corneal wound healing and progenitor
cells using novel NBCs and DNA demethylating agents. Aim 2. To unravel changes in gene expression and
cell populations in diabetic corneal epithelium by scRNA-seq following treatment with combined
pharmacological agents. Aim 3. To produce and characterize differentiated corneal epithelium with non-
diabetic properties in air-lifted cultures using diabetic iPSC-derived limbal-like epithelial cells.
Our aims fit well major initiatives of the NEI Strategic Plan 2021: (1) A game-changing advance – gaining
single-cell resolution in transcriptomic analyses, (2) Explore different cell therapies and tissue models derived
from iPSCs, and (3) Optimize gene delivery for the eye including non-viral systems, such as nanoparticles.

Public health relevance
Relevance of the proposed research project to public health The application addresses PA-20-185 goal as a Research Project Grant on new ways of treating stem cell and wound healing defects in diabetic corneal disease. We will focus on normalizing human diabetic corneal epithelial stem cells through the iPSC technology, as well as through a combination of nano and epigenetic therapy for maximum effect. If successful, the proposal may have a high impact for future treatment of frequent wound healing-related corneal problems in diabetic patients.